Optimizing surgical decision-making for premalignant pancreatic cysts

PROJECT SUMMARY AND ABSTRACT
Pancreatic cysts are common lesions that are frequently detected incidentally on imaging scans. Intraductal
papillary mucinous neoplasms (IPMNs), the most common of these lesions, have the potential to harbor cancer
or develop into cancer over time. Treatment options include either a high-risk operation or active surveillance,
which risks leaving a potentially curable cancer untreated. The decision between surgery and surveillance
requires knowledge about the risk of cancer in the lesion, the risk of surgery required to remove it, and a
patient's individual preferences regarding various possibilities, such as leaving a potential cancer untreated or
undergoing an unnecessary surgery. In practice, this treatment decision currently relies on cancer risk
estimates that are flawed because of biased samples and recommendations from treatment consensus
guidelines that do not incorporate patients' preferences. This K08 proposal will address the following three
specific aims: Aim 1: Quantify individualized risk of cancer in IPMNs; Aim 2: Elicit patients' preferences to
inform decisions about surgery versus surveillance for IPMNs; Aim 3: Develop a decision model for choosing
between surgery and surveillance for IPMNs. This study is innovative in its reducing bias in estimates of cancer
risk for patients with IPMN; its elicitation of patient preferences for patients with precancerous lesions; its
application of a modeling approach to individualized decision making; and its development of a decision
analytic model that can be tailored to patients' risk thresholds. Our findings will inform a subsequent R01 to
evaluate the effects of a prescriptive decision model on treatment decisions and outcomes. The candidate is a
surgical oncologist with education and experience in health policy and health services research whose long-
term goal is to improve the quality of surgical decisions, particularly for treatment of the many premalignant
lesions that are identified incidentally. The specific objectives of this career development award are to (1)
obtain training in risk prediction methods using real world data; (2) acquire expertise in preference elicitation
and shared decision making; and (3) build expertise in decision modeling. This K08 award would position the
candidate to become a leader in research to improve surgical decision-making.

Public health relevance
PROJECT NARRATIVE Intraductal papillary mucinous neoplasms (IPMNs) are common types of cysts in the pancreas that can become cancerous over time. This study will predict the likelihood that a cyst will become cancerous, measure patients' treatment preferences, and create a decision model to guide patients and surgeons in the choice between surgery or surveillance for these lesions.